Balancing motivation through VTA GABA/Glutamate co-transmission

PROJECT SUMMARY
Identifying the neural circuit mechanisms underlying both homeostatic and uncontrolled motivation are
crucial for developing more targeted and effective therapeutic treatments for neuropsychiatric disorders like
major depression or bipolar disorder. Within mesolimbic brain reward circuitry, the ventral tegmental area
(VTA) is a major regulator of both reward and aversion. While generally reduced to its dopamine projection
neurons, the VTA also contains neurons that co-release inhibitory GABA and excitatory glutamate and, similar
to dopamine projections, can modulate motivation. However, the functional role of this GABA/glutamate co-
release is still not well understood, and major questions regarding their role in positive vs. negative
reinforcement remain. In particular, why would neurons simultaneously send an inhibitory and excitatory
signal? This set of proposed experiments will systematically test the hypothesis that VTA GABA/glutamate co-
release serves as a mechanism to balance postsynaptic activity and motivation in a homeostatic manner.
Using optogenetics to drive VTA GABA/glutamate co-release in downstream structures that regulate mood and
motivation, I will apply gene-editing tools (CRISPR/Cas9) to test the selective contribution of GABA vs.
glutamate release in behavioral reinforcement (Aim 1). I will then apply chemogenetic approaches and chronic
behavioral manipulations that alter postsynaptic activity to test the net in vivo effect of optogenetically driving
VTA GABA/glutamate co-release using in vivo calcium imaging (Aim 2). These experiments will reveal basic
mechanisms of neurotransmitter co-release and uncover their role within mesolimbic circuitry in balancing
motivation and preventing prolonged excitation/inhibition of efferent structures associated with extreme
motivational states. The capability of GABA/glutamate co-release to normalize activity can provide a novel
target for treating disorders of imbalanced motivation such as bipolar disorder or depression. A strong
interdisciplinary team of faculty mentors and experts will provide the scientific training required for these
proposed experiments (gene-editing and fiber photometry) as well as professional development training to
facilitate a successful transition to the R00 phase of this proposal. During the R00 phase, I will unify my prior
expertise with newly acquired skills to determine the physiological and behavioral role of a newly-described
VTA GABA/glutamate projection to amygdala. Using in vivo calcium imaging, I will first monitor activity of VTA
GABA/glutamate terminals in amygdala during an effort-based instrumental sucrose task, and will then identify
the net effect of optogenetically stimulating VTA GABA/glutamate terminals on cell-defined amygdala
populations (Aim 3). These results will significantly expand our understanding of the role of VTA co-release in
complex motivated behavior relevant to models of bipolar disorder and depression, and will crucially pave the
way for more targeted approaches that form the basis my independent research program.

Public health relevance
PROJECT NARRATIVE Uncontrolled motivation and mood underlies major depression and bipolar disorder. Within brain reward circuitry, co-release of both inhibitory and excitatory signals by the same population of neurons is a newly identified mechanism, and its functional role is not completely understood. This proposal seeks to pinpoint how these co-releasing neurons normalize rewarding and aversive motivational states in an effort to identify potential new therapeutic targets that alleviate symptoms of depression or mania.